Molecular Basis and Regulatory Mechanisms of Exosome Secretion

ABSTRACT
Exosomes are small extracellular vesicles secreted by cells. Exosomes carry bioactive molecules such as
signaling proteins and mRNAs, and potently affect the pathophysiology of their recipient cells. The project funded
by my R35 grant “Molecular Basis and Regulatory Mechanisms of Exosome Secretion” (R35 GM141832) aims
to understanding the molecular mechanisms that control the biogenesis and secretion of exosomes, and the
regulation of exosome biogenesis by oncogenic signaling. A combination of molecular biology and biochemistry
approaches were proposed to understand exosome secretion at the molecular level. Molecular cloning and
protein analysis will be performed through the project. In this proposal, supplement fund is requested for the
purchase of a Bio-Rad documentation system to replace our broken and outdated unit. This is a basic piece of
equipment for the capture and storage of the images of nucleotide acid and protein gels, and is indispensable
for the accomplishment of the goals proposed in the parent R35 grant.

Public health relevance
PROJECT NARRATIVE: Exosomes play an important role in many pathophysiological processes such as neurodegeneration and cancer immune suppression. Studying the molecular basis and regulatory mechanisms of exosome trafficking will help us understand how cancer cells use exosomes for their progression. The study will bridge basic exosome cell biology and cancer biology. A protein and nucleotide acid quantification device is a basic lab equipment essential for our study of the biogenesis, secretion and function of exosomes proposed in my R35 grant.